Role of uncoupling protein-2 in alcoholic cardiomyopathy

for submission of references.) Listfull name, institution,and department of individuals submitting reference letters. 1) John L. Ricci, PhD, New York University, Dept. of Biomaterials and Biomimetics 2) Robin S. Schroeder, MD, UMDNJ - New Jersey Medical School, Administration 3) John P. Reeves, PhD, UMDNJ - New Jersey Medical School, Dept. of Pharm. and Physiol. Other Items (list): Personal Data Page for Fellowship Applicants 4) Andrew P. Thomas, PhD, UMDNJ - New Jersey Medical School, Dept. of Pharm. and Physiol. Section 4 -- Appendix (3 collated sets. No page numbering necessary. Not to exceed 3 publications; 2 for predoctoral candidates.) [] Check if Appendix is included